TARGETED PROSTATE ABLATION WITH TRANSURETHRAL MULTISECTORED US APPLICATORS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Real Time MR-Guided Prostate Ablation with Transurethral Multisectored Ultrasound Applicators and Multi-slice Treatment Planning Introduction: The purpose of this work was to improve targeted prostate ablation with transurethral multisectored ultrasound applicators. To do this, an integrated imaging platform was developed to minimize setup and treatment time and also provide real-time temperature feedback. We incorporated integrated device localization, prostate-specific planning, and multi-slice MR thermometry in a single platform. We also developed temperature feedback control points which are transferred externally for automated control of ultrasound power. Methods: Three pulse sequences were incorporated into our real-time imaging platform based on RTHawk: one for device visualization, a MR-tracking sequence for tracking coil and catheter localization, and a thermometry sequence. The software was divided into two parts: localization and planning/treatment monitoring. For verification, a catheter with two tracking coils was inserted into a phantom placed in a GE Signa Excite 3.0T scanner. After acquisition of the MR-tracking sequence, we tested whether the control software was able to automatically acquire a localization sequence with the catheter centered in the image. In a second test, two interstitial applicators were placed inside a gel phantom. Regions of interest (ROIs) were defined in transverse slices, and the mean ROI temperatures were transmitted to external power control software. This external program monitored treatment of the target volume, shutting it off once adequate heating was achieved. To read about other projects ongoing at the Lucas Center, please visit http://rsl.stanford.edu/ (Lucas Annual Report and ISMRM 2011 Abstracts)